Hawaii Pacific Islands Mammography Registry

PARENT PROJECT SUMMARY / ABSTRACT
Despite recent advances in early detection and treatment, breast cancer remains a major cause of morbidity
and mortality. Native Hawaiian women have the highest breast cancer incidence in Hawaii despite their
favorable reproductive patterns. Japanese American women now experience the same breast cancer risk as
non-Hispanic White women Further, advanced breast cancer rates are considerably higher in Asian American
Women in Hawaii and the Pacific compared to the US mainland, 15% versus 9%. The absolute risk of invasive
cancer and advanced cancer in these groups of the US population is not known. Our long-term goal is to
develop accurate and validated breast cancer risk biomarkers that can contribute to screening strategies for
Asian groups with diverse breast cancer risk profiles who to date have not been well represented in breast
cancer cohorts and clinical trials. The Hawaii Pacific Islands Mammography Registry (HIPIMR) will be the
source to identify and validate novel image biomarkers for the diverse ethnic groups of this region with varying
risk factor profiles including Native Hawaiians, Japanese, Filipino, Chinese, and other ethnic groups.
Combining San Francisco Mammography Registry and HIPIMR cohorts will give us the statistical power to
describe the risk of invasive and advanced cancer in Asian groups. Our central hypothesis is that standard
breast cancer risk factors and image factors and their prevalence are different in the diverse populations found
in high concentrations in the Pacific (Hawaii, Guam, American Samoa) and Asian ethnic groups in the
mainland US compared to non-Hispanic White, non-Hispanic Black and Hispanic women. We plan to test the
hypothesis that using risk factor profiles and next-generation breast composition and texture features across
Asian groups, the fastest growing segment of the US population,9 and NHPI ethnic groups will improve cancer
risk prediction. Our specific aims are as compared to non-Hispanic White women: 1. Examine clinical risk
factors and their association with invasive and advanced breast cancer in women undergoing breast cancer
screening by Asian (Japanese, Filipino, Chinese) and Native Hawaiian Pacific Islander (AANHPI) ancestry, 2.
Identify next-generation breast imaging characteristics from 2D and 3D mammography, including volumetric
breast density, calcifications, masses, texture features, and their association with invasive and advanced
breast cancer for AANHPI women, using advanced artificial intelligence and machine learning approaches, 3.
Identify the combination of clinical risk factors and image factors associated with invasive and advanced breast
cancer risk among AANHPI women. This study addresses the need for accurate identification of defined
clinical and radiomic risk factors among AANHPI populations and their relation to breast cancer risk to improve
outcomes for these women.

Public health relevance
PARENT PROJECT NARRATIVE The proposed studies are relevant to public health because they have the potential to identify women at high risk of breast cancer using ethnic-specific models. Thus, this advance is expected to have a high impact to the health and well-being of women because women at high risk may choose to alter the breast cancer screening frequency for earlier detection or to participate in risk reduction strategies, such as lifestyle modification. Both approaches will reduce breast cancer mortality. This is relevant to the part of NIH's mission which focuses on the prevention of disease by supporting research in the prevention and early detection of human diseases.